Core A: Administration and Biostatistics

PROJECT SUMMARY – CORE A
In this competing renewal P01 application, the Administrative/Biostatistics Core (Core A) will provide 1) a
structure to facilitate effective interactions toward accomplishment of the aims of this Program Project and
specifically will foster and promote the goals of the Program and each component (cores and projects) by
providing scientific direction, administrative support, oversight, integration of P01 Program activities ensuring
operational efficiency and 2) biostatistics and other statistical support for the Program. The Specific Aims of the
Core A are: 1)Provide research direction by setting the research agenda to utilize the HTLV-1 T-cell
immortalization model to gain understanding of the microenvironmental, cellular, and viral factors that lead to
progression to leukemia, and with this knowledge, to identify unique targets for diagnosis and treatment of HTLV-
1 infection and adult T-cell leukemia and related leukemia/lymphoma. 2) Ensure operational efficiency for
Program components by providing centralized grant administration, information dissemination, budget data
processing, and exchange of information and services. 3) Promote integration of the three Research Projects
and the two Cores to advance interaction among the investigators and between the two PPG institutions. 4)
Provide biostatistics support for the three Projects and the two Cores of the P01 Program. Core A will ensure
that all components of the Program work seamlessly together to accomplish the Overall and specific project
goals of the P01 Program.